Developing Data-Driven Clinical Signatures for People Who Experience Hallucinations

PROJECT SUMMARY
Hallucinations are prevalent in the context of a wide variety of mental disorders but also occur in approximately
10% of the general population. Hallucinatory experiences are readily identifiable by those experiencing them,
but they are not always indicators of conditions that lead to serious negative outcomes such as
hospitalizations, use of emergency services, and suicide attempt. Our risk evaluation capabilities are
hampered, in part, by the limitations of our assessment strategies which typically involve resource intensive
clinical interviews, administered by trained clinicians, in clinic settings. Ubiquitous smartphone technologies
offer us novel opportunities to administer behavioral measures that can capture the experience and impact of
hallucinations at a scope, scale, and ecological validity that far exceed clinic-based assessment capabilities.
Applying powerful computational methods to the rich data collected using mobile behavioral tasks has the
potential to yield tools for identification of those at heightened risk for major clinical and functional impairments.
In response to RFA-MH-23-105, we propose to recruit a large sample of people experiencing hallucinations to
install a smartphone behavioral measurement package that will prompt them to complete targeted brief self-
report measures, audio diaries describing their hallucinatory experiences, and validated audio-administered
verbal memory tasks in their own environments. Participants will also complete clinical outcome measures
prospectively. Our team will derive data-driven clinical signatures from the mobile behavioral tasks to predict
individual differences in severe negative outcomes among people experiencing hallucinations; identify and
mitigate bias in modelling across groups defined by race, sex, and age; examine whether adding smartphone-
captured behavioral data to information that is typically available in the clinical record improves model clinical
utility; and produce machine learning-ready data structures that adhere to FAIR (Findable, Accessible,
Interoperable, Reusable) principles, and can be shared with the broader scientific community for ongoing
iterative testing and refinement. If successful, the project will produce data-driven tools that will advance our
ability to allocate the right clinical resources, at the right time, to the right people.

Public health relevance
PROJECT NARRATIVE Our team proposes to collect data from a large sample of people who experience hallucinations using smartphone behavioral measurement tools. With the aid of innovative computational modelling strategies, these data will be used to develop “clinical signatures” that indicate which individuals are at heightened risk for severe outcomes such as hospitalization and suicide. If successful, these measures and models can be used to guide scalable clinical decision making, resource allocation, treatment, and impactful prevention efforts.